The Impact of HCV Treatment in HIV/HCV coinfected and HCV monoinfected Incarcerated Persons on HCV Elimination

Summary/Abstract
In the U.S., 2.7 million individuals are estimated to have chronic HCV infection which includes nearly 1.3 million
individuals in correctional facilities. Injection drug use remains the most common route of HCV transmission
and in a recent New Orleans, Louisiana sample, 77% of people who inject drugs (PWID) had acquired HCV in
the past. Moreover, it is estimated that 89% of PWID have experienced incarceration. HCV coinfection with
HIV is also particularly common with approximately 25% of people living with HIV (PLWH) also coinfected with
HCV. Furthermore, about 80% of PLWH who inject drugs also have HCV. As HIV-related morbidity and
mortality have declined among PLWH in the ART era, HCV, a leading cause of liver cancer and liver failure,
has emerged as an important cause of morbidity and mortality especially among PWID. PWID and PLWH are
disproportionately represented in incarcerated populations.
The purpose of this research proposal is to investigate the impact of HCV treatment of HIV/HCV coinfected
and HCV monoinfected incarcerated persons on HCV elimination. Of particular importance is understanding
why safe, curative treatment has not reached most of the incarcerated HCV infected persons who largely are
unaware of their infected status. The high cost of HCV treatment is a major reason for this knowledge gap.
High treatment prices provide an enormous incentive for states to shroud the epidemiology and treatment of
HCV. Subtle and even overt barriers to testing and treatment are sustained to diminish the net economic
impact. Accordingly, relative to HIV, little HCV testing and treatment has occurred in correctional facilities in the
U.S. Louisiana removed the cost of medications as a factor by establishing an alternative payment strategy
with the goal of treating 80% of HCV infected persons by 2024 in their HCV Elimination Program. Under the
program, Louisiana pays the same amount for HCV medications no matter how many persons are treated.
Thus, now for the first time, we have the opportunity to investigate rigorously the burden of HCV in the
correctional system in a U.S. state, the dynamics of incarceration, and the resulting prevalence of infection.
We want to apply this new knowledge to estimating the potential impact of treatment on community HCV
transmission and mortality. In the next cycle, we propose research to achieve these aims: (1) To characterize
the dynamics of HCV infection in the correctional system among HIV/HCV coinfected and HCV monoinfected
incarcerated persons; (2) To assess treatment impact as the trajectory of decline in HCV viremia among HCV
antibody positive incarcerated persons and whether this trajectory differs between those with and without HIV;
(3) To disentangle the impact of the correctional HCV treatment program on HCV viremic decline, and to
assess the impact of scale-up of correctional treatment programs on HCV incidence and mortality in Louisiana
and elsewhere.

Public health relevance
Project Narrative Hepatitis C virus (HCV) infection is a significant public health challenge especially among people who inject drugs (PWID) and people living with HIV (PLWH), populations disproportionately represented within the Department of Corrections. To improve the HCV care continuum, the Louisiana Department of Health launched a comprehensive HCV Elimination Plan that includes an alternative payment strategy to provide access to HCV medications and a peer-support treatment program, Connect for Cure, within correctional facilities. In this project, we will investigate the impact of HCV treatment in HIV/HCV coinfected and HCV monoinfected incarcerated persons on HCV elimination.